Neuron-macrophage interactions in models of chemotherapy-induced peripheral neuropathy

Summary/Abstract:
Chemotherapy-induced peripheral neuropathy (CIPN) affects over 3 million people in the US without effective
treatment. CIPN predominantly affects nociceptive (pain-sensing) nerve terminals, and often manifests as
chronic debilitating pain in patients. Chemotherapy-induced inflammation strongly correlates with the onset of
and persistent neuropathic pain. We propose to investigate peripheral interactions between macrophages, the
most abundant immune cell type residing in skin, and nociceptive nerve terminals in CIPN. Molecular profiles of
macrophages change continuously depending on their extracellular environment, allowing them to transition from
resident to activated states. While pro- and anti-inflammatory activation of macrophages has been extensively
studied, recent studies revealed many intermediate forms during the transition. How these are linked to
pathological progression of nerves is still poorly understood, and we propose to fill this gap by using two
complementary systems, Drosophila and mouse CIPN models. We will test the hypothesis that modulating
macrophage activation could prevent peripheral sensory neuron hypersensitivity in CIPN. In our
preliminary work, we established a Drosophila model to study neuron-macrophage interaction in vivo and found
that macrophages activate and transition into different intermediate forms in a time-dependent manner that
corresponds to nociceptive neuron phenotypes. Leveraging a single-cell quantitative approach using deep
learning cell detection in situ, we found that expansion of activated macrophages peaks preceding morphological
degeneration of neurons with a robust increase in selected pro- and anti-inflammatory genes. We further found
a significant reduction in anti-inflammatory macrophages at a later stage, indicating an immune state switch
between intermediate and late pathological stages. In search of genes that could modulate macrophage
activation to promote neuronal health while not interfering with their roles in host defense, we identified
mesencephalic astrocyte-derived neurotrophic factor, MANF, as a potential gene target for CIPN prevention.
MANF is a potent regulator of immune activity, and its overexpression reduces the pro-inflammatory pathway
and promotes activation of the anti-inflammatory pathway. In support, our preliminary results demonstrate that
augmenting MANF prevents neuron phenotypes in Drosophila and mouse CIPN models, consistent with our
hypothesis. We propose to characterize chemotherapy-induced macrophage profiles and investigate how MANF
modulates macrophages to prevent neuronal toxicity in Drosophila in vivo and mouse neuron-macrophage co-
culture CIPN models. Our proposal has a high potential to contribute to effective anti-inflammatory treatment for
promoting neuronal health in CIPN.

Public health relevance
Project Narrative: Chemotherapy-induced peripheral neuropathy (CIPN) strongly correlates with chronic inflammation and causes debilitating pain in patients. Mesencephalic astrocyte-derived neurotrophic factor (MANF) shows promising results in protecting neurons in models of nerve injuries and neurodegenerative diseases via modulating immune activity and may serve as a promising target for preventing painful sensory neuropathy. We will use Drosophila and mouse models to characterize chemotherapy-induced macrophage profiles and investigate how MANF modulates macrophages to prevent neuronal toxicity in CIPN models.